Persistent Organic Pollutants and Cognitive Decline in the Elderly

ABSTRACT SUMMARY Aims: A longitudinal study is proposed to examine exposure to persistent organic pollutants (POPs) and change over time in neuropsychological function in older men and women. The focus will be on learning, memory, and affect, but other cognitive domains and motor function will also be investigated. The role of thyroid function as an intervening variable also will be evaluated. Significance: The proposed study is significant because it will fundamentally advance our knowledge of how exposure to POPs typical of the general population may contribute to the age-related declines in cognitive and motor function. This is an important public health concern, given the aging of the American population and the ubiquitous of these exposures, and the proposed project will significantly move the field forward, ascertain potentially modifiable risk factors, and identify high risk populations. Innovation: The proposed project is innovative because it is one of only a few studies that have examined whether neurotoxicants may exacerbate age-related nervous system deficits, and is the first to evaluate this issue longitudinally in regard to POPs. It is also the first to examine the role of thyroid hormones and thyroid binding proteins as intervening variables. Preliminary Studies: The proposed project builds upon a cross-sectional study of polychlorinated biphenyls (PCBs), polybrominated biphenyl ethers (PBDEs), and perfluorinated compounds (PFCs) among older residents of upper Hudson River communities in NY from 2000 to 2002. The results to date provide strong support for the approach outlined in this proposal, especially in regard to learning, memory and depression. Approach: Of the 253 persons in the parent project, 213 were alive and had a local address as of December 31, 2012. They will be contacted and invited to participate in a follow-up interview, neuropsychological testing, and serum analysis for PCBs, PBDEs, PFCs, and thyroid hormones analogous to that performed 12 to 14 years earlier. Subtle deficits in memory and learning, executive function, visuospatial function, reaction time, fine motor control, and affective state will be measured and change in these domains over time will be evaluated in relation to PCB, PBDE, and PFC concentrations, using statistical methods for longitudinal data and adjusting for both time-static and time-varying covariates. A mediation analysis will also be conducted to evaluate the role of thyroid biomarkers as intervening variables linking POPs to neuropsychological function. Propensity analysis, inverse probability weighting, and multiple imputation methods will be used to adjust for the possibility that persons who performed poorly initially may be less likely to participate in the second assessment. The cross-sectional results strongly support the study hypotheses and the likelihood of success is enhanced by the experience and expertise of the research team.

Public health relevance
PROJECT NARRATIVE This study will examine how exposure to environmental chemicals affects nervous system function and thyroid hormones in older men and women who live in upper Hudson River communities. They will be interviewed, asked to give a blood sample, and tested for learning and memory, attention, muscle coordination, and mood. The results will be compared to similar information collected from the same persons in 2000 - 2002 to see if those with greater exposure to environmental chemicals had greater age - related changes in nervous system function or thyroid hormones than persons with lower exposure.